Studies of HHV-8 vIL-6 Function

DESCRIPTION (provided by applicant): Kaposi's sarcoma- and B cell lymphoma-associated human herpesvirus 8 (HHV-8) specifies particular proteins that are believed to contribute to angioproliferative and malignant pathogenesis. Key among these is the interleukin-6 homologue, vIL-6, which via its signal transducing properties promotes angiogenesis, cell proliferation and cell survival. The expression of vIL-6 is maximal during lytic, productive replication, but we have demonstrated that it is also expressed as a bone fide latent protein in primary effusion lymphoma (PEL) cells, and, coupled with its predominant intracellular localization, acts in an autocrine manner via ER-initiated intracellular signaling to support PEL growth and survival. Other latency functions of vIL-6, mediated from the ER compartment, may be operative. Unpublished data from this laboratory have established that depletion of latently expressed vIL-6 in PEL cells leads to increased RTA expression and to lytic reactivation, suggesting a role of vIL-6 in regulation of latent-lytic switching. During chemically-induced lytic reactivation, we have found that vIL-6 is a negative regulator of virus production in both endothelial and PEL cells. The present application will focus on the molecular basis of vIL-6 retention and signaling within the ER compartment and the mechanisms and roles of vIL-6 function in relation to virus biology, in part by utilizing the unique reagents and knowledge that we have acquired from our previous studies of vIL-6. The three aims will examine: (1) the roles of ER proteins calnexin and VKORC1 in vIL-6 localization and activity; (2) ER-localized signaling and functions of vIL-6; (3) the role of vIL-6 in the regulation of latent-lytic switching and productive replication. These areas of study are novel and, we believe, of considerable value to future development of anti-viral and therapeutic strategies. PUBLIC HEALTH RELEVANCE: Human herpesvirus 8 (HHV-8) is linked etiologically with endothelial and B cell malignancies and encodes a cytokine homologue, referred to as viral interleukin-6 (vIL-6), which is believed to contribute to disease development, but its role in virus biology is unknown. Our own data have revealed that vIL-6 is essential for growth and survival of cells latently infected with HHV-8 and that it regulates the switch to productive replication and efficiency of virus production. The goal of the proposed research is to characterize the major mechanisms by which vIL-6 functions in these processes, research that will have direct relevance to the development of novel anti-viral strategies that could lead to effective prevention and treatment of HHV-8- associated diseases.

Public health relevance
Narrative: Human herpesvirus 8 (HHV-8) is linked etiologically with endothelial and B cell malignancies and encodes a cytokine homologue, referred to as viral interleukin-6 (vIL-6), which is believed to contribute to disease development, but its role in virus biology is unknown. Our own data have revealed that vIL-6 is essential for growth and survival of cells latently infected with HHV-8 and that it regulates the switch to productive replication and efficiency of virus production. The goal of the proposed research is to characterize the major mechanisms by which vIL-6 functions in these processes, research that will have direct relevance to the development of novel anti-viral strategies that could lead to effective prevention and treatment of HHV-8- associated diseases.